Defining mechanisms of diverse CRISPR-Cas complexes

Project Summary
This proposed administrative supplement is for the purchase of a mass photometer to support
research related to the parent grant as well as other NIH-funded research in the PI's
department. This instrument will allow precise measurement of the formation of macromolecular
complexes, providing information on the stoichiometry of the complex, the distribution of
compositional states, and the affinity of complex formation. The instrument will support research
related to multiple funded NIH awards, including the PI's research on CRISPR-Cas complexes
involved in all stages of bacterial immunity. The instrument will be housed in the Iowa State
Cryo-EM facility, where it will become part of the general sample screening workflow, while also
allowing for more in-depth biophysical analysis. Facility users will be trained by the facility
manager on all aspects of instrument operation and data analysis. The Cryo-EM Facility is
administered by the Office of Biotechnology, which is under the direction of the Office of the
Vice President for Research at Iowa State. The two offices will provide funds to offset the cost of
the instrumentation and to purchase a service contract. User fees will be collected to provide
funding for recurring instrument costs. The instrument fills a need for a biophysical technique to
measure complex formation that is not possible using existing equipment on the Iowa State
campus.